Viral and host factors in neuroinvasion of encephalitis alphaviruses

SUMMARY
The long-term objective of this multi-PI project is to determine how host-pathogen interactions
impact entry, infection, and spread of encephalitic alphaviruses in the central nervous system
(CNS). The vector-borne neurotropic viruses, Venezuelan, eastern, and western equine
encephalitis viruses (VEEV, EEEV, WEEV), invade the CNS after subcutaneous inoculation and
initial interaction with immune sentinel cells, such as macrophages and dendritic cells (DCs)
(VEEV), or fibroblastic, osteoblastic and other cell types (EEEV, WEEV). Both EEEV and VEEV
enter the brain via the hematogenous route but only VEEV is found in olfactory neurons. The
CNS lacks intraparenchymal lymphoid tissues and cannot initiate adaptive immune responses;
thus, it mainly relies on innate responses communicated through local and systemic cytokine
secretion, which modulate the status of resident neural cells and limits viral neuroinvasion and
the extent of infection. CNSresident cells may include multiple members of the neurovascular
unit (NVU) such as brain microvascular endothelial cells (BMECs), pericytes, astrocytes,
microglia and neurons themselves that may be infected directly or acted upon by regionally or
systemically produced cytokines. VEEV is a highly lymphotropic virus eliciting robust serum
cytokine responses after peripheral inoculation, while EEEV tropism in lymphoid tissues is
highly restricted, and serum cytokine responses are much lower, and in the case of type I IFN,
often undetectable. In published studies, two primary virulence factors for EEEV in human and
murine models defined mechanisms that suppresses replication in immune sentinel myeloid
cells and greatly limit innate immune (especially interferon) responses to EEEV infection in vitro
and in vivo1. How these factors, which include the presence of binding sites for the
hematopoietic cell-specific microRNA, mir142-3p, in the EEEV 3' untranslated region (UTR)1-3,
and efficient binding of EEEV to heparan sulfate (HS) receptors on cells4,5, impact the
differential neuroinvasion and CNS dissemination of EEEV versus VEEV is unknown.
Supporting the idea that differences in EEEV versus VEEV cytokine induction may be critical to
neuroinvasion, we found that type I IFN-dependent responses directly regulate transcytosis,
preventing alphavirus entry across the BBB and modulating the level of infection and injury in
cells of the NVU6. Thus, systemic and local cytokine responses during alphavirus infection
induce BMECs and pericytes to regulate viral entry at the blood-brain barrier (BBB) and
potentially other CNS sites. This is consistent with the relative extent of virus replication at
terminal stages of disease as EEEV exhibits widespread infection of neurons throughout the
CNS while VEEV replication is much more focal (unpublished). Using mutant VEEV and EEEV,
novel viral vectors that express indicators of infection (e.g., eGFP, nanoLuciferase) in vivo, we
have observed regional heterogeneity in dominant sites of entry between these alphaviruses.
With regard to BBB entry, our studies also indicate that viral neuroinvasion precedes BBB
disruption, utilizing caveolin-mediated transcytosis to cross the BBB. We hypothesize that type
I interferon responses differentially impact the entry and infection of EEEV and VEEV at
the NVU via virus-specific induction of replication-restricting innate immune responses.
To test these hypotheses we will:
Aim 1. Define alphavirus and host specific mechanism in vitro that regulate viral entry
and infection at the NVU.
Aim 2: Define the in vivo functional role of type I IFN in protection from alphavirus
neuroinvasion at the NVU.

Public health relevance
RELEVANCE In 2019, EEEV exhibited an unprecedented outbreak in the United States resulting in 38 confirmed cases and 15 deaths, as opposed to a recent average of 5-8 cases and 1-3 deaths. The outbreak occurred throughout the EEEV-endemic areas of the US (northern tier of eastern states, New England, south eastern seaboard and gulf coast) suggesting a nation-wide increase in virus activity (www.cdc.gov/easternequineencephalitis). Considering the virulence of EEEV, this raises significant concerns regarding the future incidence of EEEV disease, which may be impacted by climate change, mosquito vector and reservoir abundance, and human activity. In contrast with EEEV, Venezuelan equine encephalitis virus (VEEV), a related member of Alphaviruses, causes a much less severe disease in humans and 0.5-1% mortality in symptomatic cases. VEEV is endemic along the gulf coast of the US and also Latin and South America. Reflecting the human virulence of EEEV and potential biowarfare/bioterrorism uses of both viruses, they have been placed on the National Select Agent Registry and the viruses are considered Category B Priority Pathogens by the National Institutes of Health.